Improving Genetic Diagnosis for African Ancestry Populations

Project Summary
People of African ancestry have been grossly underrepresented in genetic studies, across domains and
disciplines. In aggregate, this is most visible through the constitution of large genetic databases like gnomAD, in
which only 14% of individuals have some African ancestry. The great majority of those African-ancestry
individuals are African American, and most commonly have a mixture of West African and European ancestry.
This means that East African populations, and other Africans living on the African continent, are even further
underrepresented in genetic studies to date. If African ancestry individuals remain underrepresented in genetic
research, they will continue to be less likely to receive accurate genetic diagnoses and less likely to benefit from
advances in genomic medicine. Here, we will use data from gnomAD, NeuroDev and NeuroGAP-Psychosis to
address this representation gap and to improve medical genetic and diagnostic pipelines for individuals of all
types of African ancestry (Aim 1). The pipeline improvements will be made immediately available through seqr,
an open access analysis platform that is available on AnVIL for use by the medical genetics community. We will
genetically characterize all participants from the NeuroDev Kenya project (NDK) and use this data to test and
improve this pipeline and identify genetic diagnoses for participants (Aim 2). Using data from NDK’s 3 hour
medical, cognitive and behavioral battery, we will conduct the largest phenotypic characterization of rare genetic
disorders in East African individuals to date (Aim 3). As described by the NHGRI Atlas initiative, syndromic
neurodevelopmental disorders often vary in their phenotypic presentation between ethnic groups. The
presentations of relatively common genetic disorders (e.g. DDX3X and 22q11.2 deletion syndromes) have not
been well characterized in non-European populations. In a collaborative analysis, we will compare the phenotypic
profiles of NDK cases and cases from the Deciphering Developmental Disorders Africa study with common
genetic disorders against those observed in European ancestry cases, as described in GeneReviews and the
G2MH network. Lastly, all data (e.g. genetic data, HPO terms) and algorithms generated by this work will be
made publicly available in order to rapidly improve medical genetics research and resources for African
communities (Aim 4).

Public health relevance
Project Narrative People of African ancestry are vastly underrepresented in both: (i) clinical genetics research and (ii) human genetics reference panels (e.g. gnomAD), which makes them less likely to receive accurate genetic diagnoses. This work will leverage data from multiple large-scale efforts to improve medical genetic and diagnostic pipelines for people of African ancestry. The NeuroDev Kenya study provides the largest phenotypic characterization of rare genetic disorders in East African individuals to date and will help to identify rare genetic diagnoses in hundreds of East African individuals.